Novel transcription factors modulating the development and function of pDCs and pDC-related cells

ABSTRACT
Plasmacytoid dendritic cells (pDCs) and pDC-related cells are developmentally related innate immune cells
capable of performing multiple functions essential for successful antiviral immune responses, including type I
interferon secretion and T cell activation. The identity, i.e., development and function, of pDCs and pDC-related
cells is controlled by the precise interaction of transcription factors (TFs). Tight regulation of transcriptional
programs is essential to promote the appropriate response to pathogens while avoiding damage to healthy
tissues. Thus, it is critical to unravel the transcriptional regulation of pDCs and pDC-related cells. Using a high-
dimensional unbiased approach, we have recently discovered two conserved TFs that are specific and highly
active in pDCs and pDC-related cells but not in other DC subsets. In two specific aims, we propose to explore
the role of these TFs in determining the development and function of pDCs and pDC-related cells. To achieve
our goal, we will take advantage of novel conditional knockout mouse models, transcription factor-
overexpressing human cell lines, and high-dimensional approaches already established in our lab. We anticipate
that findings from this proposal will bring into light novel mechanisms of transcriptional regulation that result in
the positive outcome of innate immune responses against viruses. Importantly, our integrated approach will
incorporate analyses of both mouse and human DCs; thus, it can reveal features that are conserved between
species. This proposal has the potential to impact the rational design of therapeutic strategies by exploring
regulatory programs determining the identity of key antiviral innate cells.

Public health relevance
PROJECT NARRATIVE Plasmacytoid dendritic cells (pDCs) and pDC-related cells are innate immune cells in charge of initiating and modulating responses to viral infections. The identity of these innate immune cells is coordinated by transcription factors regulating gene expression. The proposed research aims to investigate the role of two novel transcription factors in determining the development and function of pDCs and pDC-related cells, potentially revealing new therapeutic targets to modulate their function during disease.